Administrative Core

ADMINISTRATIVE CORE
Project Summary: The proposed project will be dedicated to advancing polycystic kidney disease
(PKD) research by providing critical oversight, coordination, and resources that remove traditional
barriers in this field. Although ADPKD is primarily associated with kidney abnormalities, it affects
multiple organs in ways apparent on routine imaging. The Center’s mission is to offer state-of-the-art,
automated tools to extract quantitative measures from MRI and CT images, revealing often-
overlooked systemic features of ADPKD. The Administrative Core will ensure the effective operation
of two integrated Biomedical Research Cores, which develop and deliver high-precision imaging
measurements critical for PKD science. Led by a senior imaging investigator from Weill Cornell
Medicine, who will work closely with team members from Cornell Tech and Rogosin Institute, the
Administrative Core will provide strong direction, oversight, and guidance, maximizing the
effectiveness of the Phenotyping Research Cores while fostering impactful collaborations across the
PKD Research Resource Consortium (PKD-RRC). The Administrative Core aims to achieve the
following objectives:
1. Optimize Core Resource Utilization: By overseeing financial operations, quality control, and
productivity, the Administrative Core will ensure efficient resource allocation and maintain a high
level of quality and throughput for PKD image phenotyping services.
2. Facilitate Cross-Institutional Collaboration: Streamlined Data Use Agreements (DUAs) will enable
broad distribution of imaging resources, data, and expertise, facilitating national and regional
partnerships that accelerate ADPKD research across multiple institutions and research centers.
3. Advance Imaging Biomarker Development: The Administrative Core will coordinate research
endeavors between the ADPKD Image Phenotyping Repository and Phenotyping Methodology
Research Cores, driving the development of innovative imaging biomarkers that push the
boundaries of phenotypic information that can be extracted from ADPKD imaging data.
4. Support and Inspire the Next Generation of Researchers: By sponsoring a summer student
program, the Administrative Core will provide hands-on training in PKD image phenotyping,
encouraging students to pursue careers in nephrology and PKD research. Trainees will gain skills
in advanced image analysis and become part of a pipeline of future PKD investigators.
Through these aims, with effective communication to promote interaction among all stakeholders, the
Administrative Core will drive innovative PKD research, strengthen collaborative networks, and
accelerate the pace of scientific discovery in the field of ADPKD.